Administrative Supplement: Model-guided design of next-generation bacterial therapeutics to treat cardiovascular disease

PROJECT SUMMARY/ABSTRACT
It is becoming increasingly evident that the composition and metabolites produced by the human gut microbiome
influence the progression of cardiovascular diseases. While we are continuing to discover important associations
between the gut microbiome and human physiology and diseases, we lack the tools and methodology to
precisely manipulate gut microbiota to benefit human health. We propose to develop computational models and
optimization frameworks to predict community dynamics and functions and design interventions to shift the gut
microbiome to desired states. We will design novel bacterial therapeutics that operate autonomously in the
mammalian gastrointestinal tract to steer the microbiome towards healthy states. These next-generation
bacterial therapeutics will sense important gut microbiome metabolites, process information, and deliver species-
specific antimicrobial proteins to reshape the dynamics and functions of this ecosystem. The performance of
these bacterial therapeutics will be characterized in vitro using synthetic human gut microbiome communities
and in gnotobiotic mouse models of cardiovascular disease. Model-guided microbiome engineering has the
potential to transform human medicine and is becoming increasingly important as scientists continue to discover
connections between the microbiome and human health and disease.

Public health relevance
PROJECT NARRATIVE Recent studies have shown close connections between the human gut microbiome and cardiovascular diseases (CVDs), which are the leading cause of death worldwide. While engineering of the gut microbiome holds tremendous potential as a novel therapeutic strategy for CVD, we currently lack the tools and methodology required to design interventions that precisely shift the structure and function of the gut microbiome. The major goals of our project are to (1) develop computational modeling techniques to design perturbations that can steer the microbiome to desired states and (2) design next-generation bacterial therapeutics that sense major gut microbiome-produced metabolites and deliver selective antimicrobials to shift microbiome states to ameliorate CVD.